A Multi-Method Study of Momentary Distress Intolerance and Combustible Cigarette Smoking

PROJECT SUMMARY
Cigarette smoking among adults with emotional distress (i.e. anxiety, depression) is a recognized health
disparity. Individuals who smoke cigarettes and experience co-occurring emotional distress (compared to those
who do not) are more dependent on cigarettes, experience more withdrawal symptoms during quit attempts,
and have greater difficulty achieving abstinence. Distress intolerance (DI), or one’s inability to withstand
aversive states, is a cognitive-emotional vulnerability implicated in the emotion-smoking comorbidity. Decades
of empirical inquiry have focused on translating DI to a smoking cessation treatment target. However, these
efforts have been met with relatively little success, which appear to reflect weaknesses in the literature’s
conceptualization and assessment of DI. To address these limitations, we propose a fresh perspective on this
research topic, by reconceptualizing DI as a dynamic intraindividual process that can be activated by various
types of distress (e.g., physical distress like pain or fatigue), and influenced by various contextual (situational)
factors. This K23 proposal outlines a well-integrated research and training plan for mentored, patient-oriented
career development. The proposed research involves a multi-method approach, to understanding how DI
varies on a moment-to-moment basis and the factors that influence it among people who smoke. Phase I of
the project will involve a qualitative investigation. Phase II will involve quantitative examination of naturalistic
momentary data via ecological momentary assessment (EMA) over a 28-day period. EMA will include
randomly sampled and self-initiated reports of DI, distress and situational context during smoking. Hypotheses
of momentary within-person internal and situational factors that influence momentary DI during smoking will be
evaluated primarily with longitudinal modeling methods. This research plan provides the necessary landscape
for experiential learning and mentored training in applying an innovative momentary model of DI, studied
through a multi-methodological approach. An impressive mentorship team with complementary expertise in
emotion and addiction, EMA and qualitative methods, social-ecological theory and intensive longitudinal
modeling, will guide training in these areas. The proposed 5-year career development period will facilitate a
successful transition to independence and aid in securing future research funding to develop and/or refine
idiographic, momentary interventions to bolster smoking cessation.

Public health relevance
PROJECT NARRATIVE Distress intolerance (DI), or one’s inability to withstand difficult experiences, physically and emotionally, is a risk factor believed to underlie the co-occurrence of cigarette smoking and emotional distress/disorders. In this mentored research development application, we explore DI as a dynamic variable that can change moment-to- moment as the result of various internal and external factors. Through the proposed multi-method study, our goal is to understand these factors that influence DI and subsequent smoking in daily life in order to inform future interventions that can help people reduce DI in the moments when they are most likely to smoke.